Physical exercise and Blood-brain communication: exosomes, Klotho and choroid plexus

Aging is the major risk factor for Alzheimer’s disease (AD). Numerous studies have confirmed that physical exercise
has positive effects in patients with AD and other neurodegenerative disorders. The majority of the studies examining
the effect of physical exercise in animal models of neurodegeneration have reported neuroprotection, improved
memory and cognitive performance. The molecular mechanisms of the interactions between the non-neuronal
systems involved in the physical/aerobic exercise and brain, however, remain poorly understood. The
antiaging protein, α-Klotho, has well-known neuroprotective activity, and recent studies demonstrated that systemic
elevation of α-Klotho protein in transgenic mice or injection of soluble α-Klotho fragment, enhanced cognition and
neural resilience in young, aging, and a murine disease model. Recent reports have suggested that α-Klotho levels
decline in brain of animal models of AD. It has been recently shown that physical aerobic exercise increases the
circulating levels of α-Klotho, and we have found that direct muscle contraction via neuromuscular electrical
stimulation significantly enhanced α-Klotho expression in the hippocampus. These findings raised the novel
hypothesis that skeletal muscle may be a regulator of circulating α-Klotho. We posit that muscle-induced stimulation
of α-Klotho may play a role in the beneficial effect of exercise on cognitive outcomes. Importantly, it has been
established that signals from periphery to the CNS are transmitted through mechanisms highly specific to choroid
plexus (CP) epithelium, and physical exercise increases the release and amount of extracellular vesicles into the
circulation. Our preliminary data demonstrate that α-Klotho is detectable at high levels in exosomes isolated from
plasma, and that muscle contractile activity increases the release and amount of α-Klotho-containing exosomes in
circulation. We also show that the exosomal cargo can transmit a signal to cells in vitro, thus affecting the expression
level of intracellular proteins. We hypothesize that the effects of physical exercise on CNS are results of signals
generated in peripheral muscles and transmitted to the brain via the CP epithelium. The signals are associated
with and depend on increased circulating levels of anti-aging protein,α-Klotho, released by muscles within
exosomes. This interdisciplinary research will integrate the expertise of AD researchers experienced with AD animal
models, analysis of AD-like pathology and omix approaches (R. Koldamova & I. Lefterov), established researchers
in biology of α-Klotho, rehabilitation, and aging (F. Ambrosio) and cell biology (C. St Croix). The goal of this proposal
is to further our understanding of the interactions between α-Klotho expression in skeletal muscles, physical activity
and brain, and to elucidate the relationship of age-related changes in skeletal muscle and progression of AD. Aim 1:
To determine if the effects of physical exercise on phenotype and gene expression in the hippocampus and cortex
are mediated by α-Klotho. Aim 2: To reveal the effect of muscle training on exosomal cargo in plasma and CSF,
and to integrate their proteomic and miRNA profiles with the phenotype and brain transcriptomes. Aim 3: To
elucidate the role of Choroid Plexus and α-Klotho in communicating signals from peripheral muscles to CNS.

Public health relevance
Project Narrative / Relevance The role of anti-aging protein Klotho in neurodegeneration and impaired cognition is poorly understood. The proposed research will determine who are the mediators of the effects of physical exercise at gene and cell level in brain the role of Klotho and how the Choroid Plexus epithelial cells facilitate the communications between peripheral muscles and brain through Blood CSF Barrier. We will investigate the role of Klotho using mice with global deletion of Klotho, complex mice expressing human APP expressing one only allele of Klotho, and procedures to isolate and profile extracellular vesicles, primarily exosomes, from plasma and CSF. The in vitro models proposed will address the question if, and how the aging brain with lower expression of Klotho, and the aging muscles with lower Klotho in exosomes released in response to physical exercise affect the brain function.